Metabolic Control of Translation in Glioblastoma

ABSTRACT
Glioblastoma represents the most common primary malignant brain tumor with a median survival of less than
2 years. Despite extensive molecular characterization, precision oncology has had little penetration in clinical
neuro-oncology, suggesting that novel therapies are needed. Many cancers, including glioblastoma, display
accelerated protein synthesis associated with upregulation of major oncogenic pathways, including
RTK/RAS, PI3K/AKT, MYC and β-catenin/WNT. In preliminary studies, we find that increased translation is
heterogeneously distributed between tumor cells. Translation is regulated by post-transcriptional
modifications of transfer RNAs (tRNAs). The human genome encodes ~500 tRNAs that recognize 61 codons
for 20 amino acids, on which more than 100 types of tRNA modifications have been identified. Dysregulation
of tRNA modifications is prevalent in cancer and often leads to altered tRNA abundance or function, resulting
in global or codon-biased translational reprogramming. We performed a CRISPR screen of tRNA regulators
to reveal critical dependencies in glioblastoma. Preliminary results suggest that tRNA regulators that integrate
metabolites may be critical to glioblastoma growth.
Dietary restrictions have been proposed as oncologic interventions. For example, high levels of methionine
are required for the growth of many cancers, and dietary methionine restriction enhances cancer treatment
through one-carbon metabolic remodeling. To date, dietary interventions for glioblastoma treatment have not
been successful, of which the most studied approach is the ketogenic diet, based on the hypothesis that
glioblastoma cells cannot utilize ketones efficiently and must rely on glucose as primary energy source.
However, response rates have varied in different trials, limiting effective clinical translation. We recently found
that dietary lysine restriction inhibits tumor growth through epigenetic remodeling of endogenous immune
responses in preclinical studies. Here, we propose to interrogate metabolic rewiring and the cellular response
to microenvironmental nutrients to regulate cellular translation in glioblastoma to inform the development of
effective dietary intervention strategies.

Public health relevance
PROJECT NARRATIVE Glioblastoma remains one of the deadliest of human cancers despite aggressive treatment, suggesting that novel therapies are needed. We will investigate how the metabolic state of glioblastoma determines how tumors generate proteins that promote their growth and resistance to radiation and chemotherapy. Dietary manipulations may increase the efficacy of other therapies for the treatment of glioblastoma.